Glycan Biomarkers for Cholangiocarcinoma

Cholangiocarcinoma (CCA) is an epithelial cancer arising in the biliary mucosa lining the
ducts that carry bile from the liver to the small intestine. CCA is the second most common type of
liver cancer after hepatocellular carcinoma (HCC) and is a highly lethal cancer. CCA is classified
based on the anatomic location into intrahepatic CCA (iCCA), perihilar CCA (pCCA), or distal
(dCCA) subtypes. The limited clinical presentation of these tumors contributes to late diagnosis
with surgery being possible in less than 25% of patients and this, combined with high tumor
recurrence after surgery, results in dismal prognosis and high mortality rates. Indeed, and in
contrast to many other cancers, the overall mortality of CCA has not significantly improved,
resulting in unsatisfactory 5-year survival rates (7–20%). The serum tumor marker carbohydrate
antigen (CA) 19-9 is used in routine practice to help CCA diagnosis and to monitor disease
progression once diagnosis has been achieved. The major limitation is the low sensitivity and
specificity of this marker, thus not allowing the early detection of CCA. We have recently identified
changes in glycosylation that occur in both tissue and serum of those with CCA. Importantly, these
glycan changes could be used to differentiate CCA tissue or serum from healthy or diseased
serum or tissue, including hepatocellular carcinoma and PSC. We hypothesize that these
changes in glycosylation observed directly in CCA tissue, and in serum, may be useful as a non-
invasive liquid biopsy biomarker of CCA. Thus, in this application we propose to develop new and
novel biomarkers of CCA based upon the glycan changes observed in tissue and serum.

Public health relevance
Our group has identified specific macromolecular changes, specifically N-linked glycans, that are altered directly in cholangiocarcinoma tissue. Importantly, these glycans can also be found in serum and these serum glycans can act as superior biomarkers of cholangiocarcinoma. In this application we will identify the proteins that contain these changes and discover new biomarkers of this cancer.